Immersive Simulation Program

A wide range of services are provided by the Immersive Simulation Program (ISP) and its staff including, scientific consultation, technological consultation and support, acting as a conduit to developers, data collection, study administration, data preparation and analysis, and arranging necessary scientific materials. The ISP also engages in communication and education about virtual reality and related technologies to the research and health care communities, and to the public. During this reporting year, several Social and Behavioral Research Branch-initiated research projects, and one project initiated within the wider NIH have been served by the ISP team. The ISP team has also conducted capacity-building research.

These currently include:

- A project related to encouraging communication about genetic risk among families (PI: Koehly): virtual reality environment planning and consultation, study design consultation
- A study of an intervention to communicate about gene-environment interaction concepts (PI: Persky): virtual environment design consultation and research
- A study about ADHD intervention (PI: Shaw/Persky): consultation, writing, planning application development
- A study about treatments for alcohol use disorder (PI: Leggio): consultation and data wrangling
- A study about pharmacogenetic testing (PI: Bonham): manuscript editing, writing, data analysis
- A study about use of polygenic risk scores in clinical practice (PI: Persky): materials design and preparation
- A study about evaluation of facial features in genomic syndromes (PI: Solomon): writing and editing

We have also played a more minor role in supporting data analysis in several other projects and analyses.

In addition to directly serving the research needs of the Social and Behavioral Research Branch and other NIH colleagues, the ISP team also conducts research and assessments to expand its own capabilities which are listed under a separate project.